Alteration and Renovation

ALTERATION AND RENOVATION SUMMARY
The OK-INBRE network includes four community colleges throughout the state, Oklahoma City
Community College, Tulsa Community College, Redlands Community College, and College of the
Muscogee Nation. Tulsa Community College (TCC) is the largest two-year college in Oklahoma.
With OK-INBRE support, TCC provides outreach activities to K12 students and teachers as well
as research experiences to freshman and sophomore students, which is enhanced by the OK-
INBRE Summer Mentoring and Research Training (SMaRT) program, allowing even more
students to be engaged in biomedical research training. Limitations in facilities, equipment, and
funding for consumable supplies are barriers to undergraduate research at community colleges,
as well as adequate space to conduct research and carry out curriculum designed to incorporate
experiments into established courses, or the creation of new courses. The proposed renovation
at TCC will increase the lab capacity in a multi-room suite that was formerly used for the
Biotechnology program, which has been discontinued. Equipment in the suite is largely unused
due to the configuration of the space. The renovation will redesign the suite to accommodate
twice the number of students as it can currently manage. It will be designed so that high-tech
teaching tools can be incorporated. The proposed renovated space will serve as a research hub
for bioscience research at the Southeast Campus and will also be available to be used for OK-
INBRE supported STEM and curriculum enhancing workshops for area high school teachers. The
improved space will dramatically expand the capacity of TCC to design and carry out research
project for students and increase the number of students who can participate in biomedical
training and help build a stronger biomedical workforce in Oklahoma, one of the primary goals of
the OK-INBRE program.